GWAS Catalog

DESCRIPTION (provided by applicant): This project will continue to deliver the high quality NHGRI GWAS Catalog content. It will provide continuity of service and scalable data flow for the user community. It will provide new and improved infrastructure for users and curators. Specific tasks include: 1) Delivery of a new graphical user interface 2) Delivery of new curatorial infrastructure supporting improved QC processes 3) Provision of portable Biomolecular data integration 'Apps' based on the Ensembl APIs delivering summary data, and simple visualization of relevant datasets e.g. LD, population specific variation and regulatory variation. Data integration and visualization tools customized for the Catalog's user groups to ensure that the high quality data in the Catalog remains highly used by a diverse set of biomedical users, projects and resources. We will explore the inclusion of new data types such as next generation sequencing data in two pilots and the project will leverage the EBI's infrastructure investment to deliver scalable processes and dataflow to meet the challenge of changing technology and interpretation of epidemiology data in the whole genome context.